Mechanistic link between mitochondrial cristae integrity and Th1 responses

PROJECT SUMMARY
Genetic and environmental factors determine individuals’ susceptibility to autoimmunity. Genome-wide
association studies of human subjects provide valuable information; however, the interpretation of these results
is complex due to intrinsic and extrinsic variations. This proposal aims to uncover the genetic basis underlying
the intrinsic propensity of T cells towards autoimmunity using a hybrid mouse system with minimum extrinsic
variations and to elucidate the molecular mechanism underlying these genetic differences. We performed a
forward genetics screen using a hybrid mouse diversity panel of 107 common and recombinant inbred strains to
examine T cell propensity. We have uncovered four significant genetic loci associated with expression of
proinflammatory cytokines. A targeted screen using deletion of candidate genes within these loci uncovered a
mitochondrial cristae morphology regulator, TMEM11, as a genetic determinant of the Th1 response. Tmem11-
/- mice show normal development and homeostasis of T cells. However, while T cell differentiation was not
affected, selective effector functions of Th1 cells, including expression of IFNg, were impaired due to the loss of
TMEM11. This impairment decreased the severity of an animal model of autoimmunity, experimental
autoimmune encephalomyelitis (EAE). Further analyses revealed that Tmem11-/- Th1 cells showed impairment
in cristae integrity and mitochondrial respiration. Among these defects, excessive mitochondrial reactive oxygen
species (mtROS) production was the underlying cause of impaired Th1 function since mitigating mtROS rescued
the defect. We also found that excessive mtROS decreased histone acetylation and activation of the Ca2+-NFAT
pathway, which are important for Ifng transcription. Based on these findings, we propose to 1) uncover the
mechanism regulating mitochondrial cristae morphology in effector T cells using high-resolution imaging
techniques and proteomics, 2) understand the relationship between mitochondrial cristae integrity and effector
T cell responses by checking the role of excessive mtROS in histone modification and the NFAT signaling
pathway, and 3) Determine the role of mitochondrial cristae integrity in T cell-mediated autoimmunity using active
and passive EAE models. This study is innovative because our forward and reverse genetics approaches
uncovered a unique tool to investigate the roles of cristae integrity and mtROS in effector T cells. Knockout of
Tmem11 provides an ideal system to determine the physiological role of cristae morphology and integrity
because TMEM11 is a regulatory protein but not a core subunit of the cristae junctional complex, and its
deficiency, hence does not influence mitochondrial biogenesis or global cellular physiology. The outcome of this
study will positively impact our understanding of the roles of mitochondrial cristae integrity and oxidative stress
in effector T cell functions and autoimmunity, which need further investigations.

Public health relevance
RELEVANCE STATEMENT This project is about finding out why some people's immune cells are more likely to attack their own body, which can lead to diseases like arthritis or diabetes. We'll use specially bred mice to study how certain genes affect these immune cells, focusing on the function of a part of the cell called the mitochondria. Our goal is to learn how changes in these cells contribute to diseases, which could help us find new ways to treat or prevent them.